The role for phase separation in oncogenesis and aberrant chromatin looping formation

PROJECT SUMMARY/ABSTRACT
Rearrangement of NUP98 gene (NUP98-r) is recurrent in leukemias such as acute myeloid leukemia (AML).
Patients with NUP98-r show poor prognosis and therapy failure. Most NUP98-r partners (>30 identified from
patients) are a DNA-binding domain of transcription factor (TF; e.g. HOXA9) or a histone-binding motif such as
Plant Homeodomain (PHD), suggesting chromatin deregulation as an oncogenic mechanism. NUP98-r fusions
invariably retain Phenylalanine-Glycine (FG) repeats, termed intrinsically disordered region (IDR), from NUP98.
How unstructured IDR contributes to oncogenesis remains elusive. Our studies of NUP98-HOXA9, an AML
NUP98-TF chimera, unveil an essential requirement of NUP98’s IDR for liquid-liquid phase separation (LLPS).
We also show that IDR and LLPS are critical for the much-enhanced genome binding by NUP98-HOXA9 and
for long-distance chromatin looping between oncogene promoters and enhancers, leading to development of
aggressive AML in mice. Our unpublished preliminary studies of other recurrent leukemic fusions (namely,
NUP98-PHD fusions and MSI2-HOXA9, a leukemia-related chimera formed by fusing a less-studied IDR of an
RNA-binding protein with HOXA9’s DNA-binding domain) all point to involvements of IDR and LLPS for
oncogenesis. Thus, we hypothesize that, due to aberrant genic fusions, a number of leukemia-related onco-
TFs and chromatin factors acquire a phase-separation-inducing IDR to establish LLPS, which confers chimera
a much more enhanced ability in genomic targeting; consequently, an oncogenic gene-expression program is
over-activated while aberrant chromatin loops are formed between oncogene promoters and enhancers, which
drives formation of aggressive leukemias. Dissection of the mechanisms underlying the IDR- and phase-
separation-mediated aberrant genome organization and oncogene activation in cancer cells shall provide new
and paradigm-shifting views as for how aggressive cancer develops, implicative of potentially new treatments
in future. Towards this goal, we will further characterize the role for the un-studied IDR (that of MSI2) in
establishing LLPS in vitro and in cells (Aim 1A) and will use primary human hematopoietic stem/progenitor
cells (HSPCs) and derived cells to define roles of IDR and LLPS in regulating genomic targeting (1B), the
target gene expression (1C), and leukemic transformation in vitro/vivo (1D) by various fusions (NUP98-PHD
and MSI2/NUP98-HOXA9). LLPS-indued chromatin looping is CTCF-independent and represents a previously
unstudied mechanism underlying 3D chromatin organization. We will further define the 3D chromatin structure
alterations caused by various NUP98-r and MSI2-HOXA9 fusions in disease-relevant cells (Aim 2A), define the
molecular mechanisms driving formation/maintenance of LLPS-dependent loops (2B), and determine the
impact of LLPS DNA loops on the sustained activation of oncogenes by using a novel CRISPR/dCas9-IDR
fusion strategy (2C). As phase-separation-competent molecules are frequently implicated in a wide range of
human cancers and diseases, both the significance and overall impact of the project are potentially high.

Public health relevance
PROJECT NARRATIVE Leukemia patients carrying the rearrangement of the NUP98 gene exhibit particularly poor clinical outcomes, demanding a better understanding of how such diseases develop. This project aims to investigate the previously less-studied oncogenic function mediated by the unstructured protein region harbored within the leukemia-associated onco-proteins, which contributes to aggressive tumor phenotypes. The outcomes of the project may help develop new therapeutic strategies in future; therefore, the proposed research is directly relevant to public health.